Targeting the B Cell Receptor Signaling Network in Lymphoma

6. PROJECT SUMMARY/ABSTRACT The goal of this project is to dissect which mechanisms the B cell receptor (BCR) signaling network employs to govern life and death cellular functions in healthy B cells, determine how the BCR signaling network is remodeled in three types of cancer with abnormal BCR signaling, and then kill malignant B cells by identifying and targeting those mechanisms which are required for survival. A combination of technologies, including measurement of signaling in individual cells from primary human tissues by flow cytometry and computational modeling of the BCR signaling network, will be used to achieve this goal. Signal transduction plays a key role in the development of healthy immune cells, and remodeling of cell signaling mechanisms drives tumor cell proliferation and suppresses apoptosis, contributing to tumor survival despite intense therapy regimens. In B cell non-Hodgkin's lymphomas, signaling through the B cell antigen receptor might be especially likely to support malignant B cells, as BCR signaling normally controls survival, apoptosis, and proliferation throughout development and differentiation. The central hypothesis of this project is that abnormal BCR signaling is required for the survival of lymphoma B cells. I have previously shown that signaling in human cancer specimens can be mapped at the individual cell level by flow cytometry and used this technology to identify cancer-cell specific alteration of BCR signaling in primary human lymphoma specimens. Here, I propose to integrate this single cell signaling profile approach with measurements of the functional outcomes of signaling, including cell death, proliferation, and gene expression. The Specific Aims are to (I) identify BCR signaling mechanisms required for contrasting functions - apoptosis and proliferation - in five stages of healthy human B cells, (II) identify abnormal BCR signaling activity in three mature B cell lymphomas and determine unique signaling features of each disease, and (III) identify abnormal BCR signaling events that are required for survival of lymphoma B cells and target these events to specifically kill lymphoma cells This project will advance cancer research by first clarifying our understanding of how signal transduction normally governs cell behavior and then by translating this mechanistic insight into a sharp understanding of critical 'targets of opportunity' in the signaling networks of malignant B cells.

Public health relevance
PROJECT NARRATIVE Incidence and death rates from lymphoma in the United States are rising more rapidly than those of any other cancer except melanoma. The goal of my project is to improve the diagnosis and treatment of human cancer by dissecting the life and death signaling biology of lymphoma B cells. Signaling allows healthy cells to sense and respond to their environment, but cancer cells often ignore or misinterpret environmental signals in order to stay alive. I have chosen to focus on the central survival signaling pathway of B cells - B cell antigen receptor (BCR) signaling - because my research and that of others provides compelling evidence that this pathway is required for the survival of lymphoma B cells. During my Ph.D. research, I invented the central technology I will use in this project - the 'single cell signaling profile.' This technique enables the tracking and measurement of signaling within every single cell within a patient's lymphoma tumor sample. A key advantage of this approach is that I can examine the effect that a drug has on tumor-infiltrating immune cells and rare, aggressive subpopulations of cancer cells. Using this technology, I will (I) determine how BCR signaling governs healthy B cells and prevents them from unregulated proliferation, (II) identify unique BCR signaling events that distinguish three different B cell malignancies, both from each other and from healthy B cells, and (III) develop methods to target and destroy the malignant B cells by interrupting the BCR signaling events required for lymphoma cell survival. At the conclusion of this research, I will have used new knowledge of signaling to create tools which can profile an individual patient's cancer cells and identify key 'targets of opportunity' in the signaling network. I aim to found my own independent research group to develop the single cell signaling profiles into a rapid diagnostic tool that will eventually suggest personalized therapeutic strategies ideally suited to kill all of the cancer cells and as few healthy cells as possible. This award would significantly advance my long term career goal of using biological and computational tools to create personalized, effective therapies for human cancer. __SpecificAimsTextDelimiter__ Targeting the B cell Receptor Signaling Network in Lymphoma 10. SPECIFIC AIMS This project will advance cancer research by first enriching our understanding of how signal transduction normally governs cell survival and then by translating this mechanistic insight to identify critical 'targets of opportunity' in the signaling pathways of lymphoma cells. I have created a technique for measuring signaling in human cancer specimens at the individual cell level by flow cytometry and identified cancer-cell specific alteration of signaling in primary human lymphoma specimens. This work forms the basis of the current proposal, which will advance our knowledge of how B cell receptor (BCR) signaling survival decisions at key developmental checkpoints in healthy B cells, identify unique BCR signaling mechanisms in primary human tumor cells from patients with three B cell malignancies, and ultimately identify and inhibit those mechanisms that are required for survival of lymphoma B cells. The central hypothesis of this project is that abnormal BCR signaling is required for the survival of lymphoma B cells. Appropriate signal transduction is essential in the development of healthy immune cells, and remodeling of cell signaling mechanisms drives tumor cell proliferation and suppresses apoptosis, contributing to tumor survival despite intense therapy regimens. In B cell non-Hodgkin's lymphomas (NHL), BCR signaling might be especially likely to support malignant B cells, as BCR signaling normally controls survival, apoptosis, and proliferation of B cells. While much of the biochemistry of BCR signaling is known, it is not clear how the selection, magnitude, and duration of BCR signaling controls diverse functional outcomes in primary healthy and lymphoma B cells. During the K99 phase, I will integrate techniques I have established for single cell measurements of signaling with assays for cellular functional outcomes, including apoptosis, proliferation, and gene expression (Aim I). This coupling of signaling with outcomes will allow me to then dissect the BCR signaling network and identify and target signaling events required for the survival of lymphoma B cells. The Specific Aims are therefore: I. Identify BCR signaling mechanisms required for contrasting functions - apoptosis and proliferation - in five stages of healthy human B cells by perturbing BCR network signaling molecules. Here I will use flow cytometry assays for apoptosis, proliferation, and gene expression in cells treated with signaling inhibitors to test the hypothesis that control of functional outcomes by the BCR is determined by the signaling activity over time of key phospho-proteins (e.g. LYN, ERK, AKT). The results of this Aim will identify mechanisms used by BCR signaling to control survival and proliferation, provide a view of healthy B cell signaling that can be contrasted with similar studies of human lymphoma samples (Aim II), and generate a computational tool for comparing signaling networks. II. Identify abnormal BCR signaling activity in three B cell malignancies and determine unique signaling features of each disease. Here I will use flow cytometry and computational biology to test the hypothesis that unique mechanisms of BCR signaling are employed by cancer B cells from three lymphomas with contrasting clinical features. Specifically, I hypothesize that follicular lymphoma (FL) B cells depend on abnormal SYK, ERK, p38, and AKT responses to antigen-mediated BCR signaling, whereas chronic lymphocytic leukemia (CLL) and diffuse large B cell lymphoma (DLBCL) cells have abnormally high tonic (ligand independent) BCR signaling. In addition, I will use single cell signaling profiles to determine whether transformation of FL to aggressive DLBCL is accompanied by a corresponding change in BCR signaling from a FL pattern to a DLBCL pattern. The identification of signaling features that distinguish each disease will provide a roadmap for using perturbations to adjust signaling outcomes (i.e. kill malignant B cells) in Aim III. III. Determine BCR signaling events that are required for survival of lymphoma B cells and target these events to specifically kill lymphoma cells. I will test the hypothesis that increased negative regulation of BCR signaling selectively removes the activity of pro-apoptotic BCR signaling effectors but leaves intact pro- survival BCR signaling via AKT and ERK that is necessary for the survival of lymphoma cells. To achieve this Aim, I will inhibit the activity of BCR signaling network proteins in primary lymphoma cells. By evaluating whether inhibition of these signaling effectors kills lymphoma cells, I will identify which components of the BCR signaling network are necessary for lymphoma cell survival. By using single cell flow cytometry assays for cell death, I will be able to compare inhibitor activity in heterogeneous mixtures of primary cells and identify which inhibitors selectively kill lymphoma cells and not healthy cells, such as tumor infiltrating T and B cells (see preliminary results), a significant advantage of my approach and expertise. This form of single cell proteomics provides several opportunities for mechanistic understanding of signaling in the heterogeneous mix of cancer and non-malignant cells found in primary tumors to guide clinical decisions. Chief among these is the long term potential to eventually tailor a patient's therapy to the biological alterations detected in the individual cells of their cancer and improve clinical outcomes, the primary goal of my career.